PLURIPOTENCY OF NOVEL TICK CYSTEINE PROTEASE INHIBITORS DURING HEMATOPHAGY

Project Summary
Ixodid ticks blood feed for several days to weeks on their hosts. Hematophagy is assisted by tick’s
saliva, which is repeatedly injected into the host skin, alternating with blood intake. Tick saliva
contains a mixture of bioactive molecules that target a broad spectrum of host defense
mechanisms to allow the tick to blood feed on the vertebrate host for several days, many of which
are host immunomodulators. Understanding the molecular interactions between tick vectors,
vertebrate hosts, and pathogens is critical in developing strategies to combat ticks and tick-borne
diseases. This proposal explores a fundamental mechanism of tick hematophagy success, mainly
regulating vertebrate host proteolytic cascades at sites of tick feeding (skin) by multiple cysteine
protease inhibitors of the cystatin family. We hypothesize that three novel Amblyomma maculatum
cystatins modulate the vertebrate host immune response during blood-feeding. We will test the
hypothesis by pursuing the following specific aims: 1) To complete the detailed functional
characterization of three novel recombinant Amblyomma maculatum salivary cystatins as
candidate host immunomodulators, 2) To investigate the role of each of the three A. maculatum
salivary cystatin genes in tick feeding and pathogen transmission success by conditional knock-
downs in ticks (RNAi) and, 3) To test the potential of artificially boosting the host humoral response
against these three A. maculatum cystatins by vaccine studies in a preclinical animal model, with
an ultimate goal that the achieved boost in the host antibody titers against tick cystatins will block
their action at the tick-host interface and may impair tick feeding and/or pathogen transmission
success. For Aim 2, we will also evaluate the use of bio-inspired hydrogels as non-invasive,
transcuticular dsRNA delivery devices that could provide a commercially scalable approach for
the delivery of these therapies to ticks in their natural environment. These aims will provide critical
reagents, tools, and data to address the crucial gap in the fundamental knowledge of the role of
redundancy of host immunomodulators in tick saliva.

Public health relevance
PROJECT NARRATIVE The increase in tick-borne disease poses a significant threat to public health in the absence of preventive measures. The goal of this project is to explore basic mechanisms of tick hematophagy success, particularly the regulation of vertebrate host proteolytic cascades at sites of tick feeding (skin) by multiple tick cysteine protease inhibitors of the cystatin family.